Development and pilot testing of a culturally-tailored smartphone-delivered intervention for commercial smoking cessation in American Indians

As many as two out of every three American Indian (AI) adults located in the northern plains region of the US
smoke commercial cigarettes. As a result, AIs in the northern plains experience rates of smoking-related cancers
as high as three-fold other races. AIs are only about half as likely to quit commercial smoking compared to other
races. Poor access and engagement with existing cessation programs has been put forward as a main reason
for low quitting in AI smokers. Our long-term goal is to develop cessation interventions for AI commercial smokers
that are wide-reaching, engaging, and culturally appropriate. NCI’s QuitGuide is a publicly available smartphone
app for smoking cessation that allows for immediate access to interactive treatment content, such as real-time
guidance on how to navigate smoking triggers, and therefore has great potential for reaching and engaging AI
smokers. However, QuitGuide does not include guidance on triggers unique to AI persons such as commercial
cigarette use at pow wows nor does it address traditional tobacco which is a spiritual practice common among
AIs in the northern plains. The lack of content on traditional tobacco use is particularly problematic because of
our team’s prior research showing that cultural references to traditional tobacco in commercial smoking cessation
messages can improve self-efficacy to quit. Our present objective is to develop and pilot test a culturally-tailored
version of the QuitGuide in AI commercial smokers. Our hypothesis is that a culturally-tailored QuitGuide will
result in greater ratings of feasibility and acceptability in AI smokers versus the standard QuitGuide. The project
builds on the Masonic Cancer Center’s and the American Indian Cancer Foundation’s research collaborations
with AI communities. Our multidisciplinary team has expertise in AI tobacco use, smoking cessation, tailoring
cancer prevention interventions to the cultural of AIs, and smartphone app development. Our community partners
represent a rurally located Tribe and an urban clinic serving AIs, both of which are located in the northern plains
region of the US. A community advisory board will oversee all activities and we have an agreement to work with
the same technology experts who created NCI’s QuitGuide app. Our first aim is to conduct in-depth interviews
among AI smokers (n=40) and key-informants (n=10) to guide the cultural tailoring of the QuitGuide that will
result in a tailored app prototype. Our second aim is to assess the preliminary feasibility and acceptability of the
tailored app prototype using iterative testing among AI smokers (two groups of n=6; N=12) and to refine the app.
Our third aim is to conduct a pilot randomized controlled trial to test the feasibility, acceptability, and preliminary
efficacy of the tailored QuitGuide app (n=40) versus the standard QuitGuide app (n=40) among AI smokers. At
the conclusion, we will have a blueprint to guide the development of a clinical trial intended to test the efficacy of
a culturally-tailored version of the QuitGuide smartphone app for AI smokers. Given that AIs in the northern
plains experience some of the most extreme smoking disparities, this culturally-tailored treatment approach could
have a meaningful public health impact on the burden of tobacco-related cancers among AIs.

Public health relevance
PROJECT NARRATIVE Commercial smoking among American Indians (AI) in the northern plains region of the U.S. is high and while many AIs want to quit smoking, lifetime quitting is lower in AIs than other race groups. Low quitting among AI may be attributed to a lack of access to or availability of smoking cessation treatment interventions that are tailored to the culture and unique needs of AIs. Through engagement of multiple AI community partners this project will produce a culturally-tailored version of NCI’s QuitGuide app with the potential to effectively combat commercial smoking among AI persons in the northern plains.